CHILDHOOD DROWNING DEATHS--NATIONAL ANALYSIS OF DEATH CERTIFICATE INFORMATION

Working in collaboration with the Consumer Product Safety Commission (CPSC) information was being abstracted from death certificates for all non-boat related drowning deaths in children and adolescents less than 20 years of age. The free text portion of the death certificate often includes important information that is not included in national mortality files. Of particular importance is the specific site of the occurrence (e.g. swimming pool, lake, irrigation ditch, etc.),as interventions to prevent drowning deaths are site specific. Results from this study will provide the first in-depth look at the circumstances surrounding drowning deaths at a national level. For 1995, 1,420 death certificates were reviewed. The site of drowning was specified on 1311 (92%) death certificates. Fifty-five percent of infant drownings were in bathtubs. In children ages 1-4 years, 56% of drownings were in artificial pools and 27% were in other bodies of freshwater. After the age of five years, children were most likely to drown in freshwater settings which accounted for 55%, 61% and 69% of drownings among 5-9, 10-14, and 15-19 year olds, respecitively. Preliminary results were presented at the May 1999 meeting of the Society for Pediatric Research and a manuscript has been submitted for publication.